Seroepidemiology of trachoma for the elimination endgame

Trachoma, caused by ocular Chlamydia trachomatis infection, is the leading infectious cause of blindness
worldwide and been targeted for global elimination as a public health problem by 2030. As we approach the
endgame, there is broad interest in the use of serologic surveys to support control programs. IgG antibody
responses to C. trachomatis in children enable accurate population-level assessments of trachoma endemicity
because they integrate exposure over time and reflect recent transmission. After years of assay development,
a key gap in the field is to formalize the epidemiologic methods used for trachoma serology surveys.
Our overall objective is to advance the methods used for the design and analysis of trachoma serology
surveys. We will assemble a large, contemporary global dataset for trachoma serology across a gradient of
endemicity, paired with clinical signs and molecular measures of infection (>100,000 blood specimens tested in
19 studies from 2010-2024). Aim 1 will develop robust methods to translate antibody response into population-
level measures of transmission from endemic settings to post-elimination. We hypothesize that as populations
approach elimination age-seroprevalence curves will flatten and seroconversion rates, a measure of force of
infection, will approach zero. We will estimate age-seroprevalence curves semi-parametrically, and derive
summary measures from the curves (e.g., seroprevalence, force of infection). We will compare serologic
measures between populations of different endemicity. We further hypothesize that different serologic
summary measures (mean IgG levels, seroprevalence, force of infection) will provide similar information about
heterogeneity in transmission. We will compare serologic measures with one-another and with separate
measures of trachoma (PCR infection, clinical signs) across geographic scales from villages to districts. Aim 2
will determine if model-based geostatistics improve the efficiency of serological survey design and enable finer
scale targeting of control programs as populations approach elimination. We hypothesize that as trachoma
approaches elimination, it will become more focal with “hotspots” of elevated seroprevalence among children
that shrink in scale from districts down to individual villages. We hypothesize that if surveys account for this
spatial structure in their design they will more efficiently monitor trachoma than random samples alone, and
control programs that use spatial predictions to make treatment decisions at smaller spatial scales could more
narrowly target antibiotic distribution. In analyses of 11 georeferenced studies that span a range of endemicity,
we will apply recent advances in geospatial design to trachoma serology and compare prevalence estimates
using the new approach with the current standard, population-based random samples. We seek to identify the
most efficient sampling strategies to inform decision making as populations approach elimination, and to study
the impact of using spatial predictions to target azithromycin at finer spatial scales. Completion of these aims
will lead to significant advances in the seroepidemiologic methods used to support the trachoma endgame.

Public health relevance
Project Narrative / Lay Language Description Trachoma is the leading cause of infectious blindness worldwide and has been targeted for global elimination as a public health problem by 2030. Population-level assessment of trachoma through antibodies in blood is a promising approach to monitor transmission as countries approach and achieve elimination. We will combine information across 19 separate field studies (>100,000 people, mainly in Africa) to develop summary methods that translate antibodies in blood into population-level measures of trachoma endemicity, and determine if using spatial information in the design and analysis of serologic surveys could improve their usefulness to trachoma control programs.